Diagnostic Toxicology Support for the VetLRN

Project Summary/Abstract The objective of this proposal is to describe our laboratory's involvement in the FDA's Veterinary Laboratory Response Network (VetLRN). It will explain how we plan to provide analytical support for the analysis of animal tissues, feeds, foods, and other matrices of concern in the event that there is a chemical contamination incident that potentially compromises the safety of our nation's animal food supply or the health and safety of livestock, companion animals, or people. We propose to participate, as needed, in the development and expansion of analytical methods designed to screen a variety of matrices for diverse and potentially harmful chemicals, including unknown compounds, using GC/MS, LC/MS, ICP/MS, ELISA, and other analytical methodologies. Laboratory personnel will participate in training exercises designed to assess the ability of VetLRN to respond to surveillance, emergency response, and recovery scenarios, participate in national and regional meetings, and assist with the development and validation of methods for the analysis of chemical contaminants. Specific objectives include: • Training of laboratory personnel in analytical methodologies needed by the VetLRN • Provision of analytical expertise to the improvement, expansion, and validation of existing VetLRN methods • Assistance with the development of new methods for the VetLRN as needed • Participation in VetLRN proficiency testing programs • Collaboration with other VetLRN member laboratories to ensure the effectiveness of the VetLRN program • Participation in surveillance, emergency response, or recovery exercises as the need arises • Effectively communicating with other VetLRN laboratories via the use of eLEXNET

Public health relevance
Project Narrative The primary objective of this project is to provide analytical chemistry support to the FDA-CVM in assuring safe and contaminant free animal and human feeds and food and to assist in surveillance, emergency response and recovery exercises as the need arises. Potential matrices of interest include animal tissues, feeds/foods, drugs, environmental matrices, and other components that may be implicated in an animal intoxication. Analytical systems to be utilized include gas chromatography-mass spectrometry (GC/MS), liquid chromatography-mass spectrometry (LC/MS), inductively coupled plasma-mass spectrometry (ICP-MS), and enzyme-linked immunosorbent assays (ELISA). The project will allow for the development and maintenance of a qualified workforce in the various methodologies to effectively and knowledgeably respond to a contamination incident and help to ensure the continued availability of laboratory investigative and surge capacity and to effectively recover from an animal food or drug- related contamination incident. __SpecificAimsTextDelimiter__ Specific Aims The specific aims of the proposed project are to 1) improve scientific knowledge in the area of analytical screening methodologies for a diverse suite of chemicals and unique food/feed matrices 2) assist with the validation of analytical screening methodologies, and 3) provide the beginnings of a national infrastructure to be able to respond to an animal/human feed/food concern.